ORAL GLULCOSE TOLERANCE TESTING IN CHILDREN FOLLOWING FUNDOPLICATION

This study will evaluate the glucose response to an oral glucose tolerance test in children who have undergone a fundoplication. It will also determine if hypoglycemia or other abnormal glucose levels often associated with abdominal surgery in children can be observed.